Revisiting ReCHARGE: ECHO Follow up on Middle Childhood and Adolescence

Beginning in fall, 2016, the UC Davis pediatric cohort, ReCHARGE, was funded with the new
Environmental Influences on Child Health Outcomes (ECHO) Consortium that encompassed
close to 80 sites. Now in year 7 of ECHO Phase 1, UC Davis has enrolled ~900 children into
ECHO from three neurodevelopmental groups of children with: autism spectrum disorder (ASD),
developmental delays (DD) without autistic symptoms, and typical development (TD); uploaded
over 55,000 data collection forms to the ECHO Cohort Data Platform, and transferred over 8000
biospecimen aliquots to the ECHO Biorepository, including DNA for SNP arrays, urine for
analyzing novel chemicals from common but understudied household products, and blood for
multiple uses. The UC Davis ECHO team led a number of analysis proposals, authored/co-
authored 40 peer-reviewed papers, with another 50 in-progress. The Team also contributed to
developing ECHO policies and participated in and led various working groups, such as
Neurodevelopment, Chemical Exposures, Epigenetics, as well as Committees on Publications,
Policy Implementation and Evaluation, and others. The ECHO-ReCHARGE cohort focuses on
the ECHO area of neurodevelopment, which is facilitated by the UC Davis MIND Institute. In
ECHO Phase 2, the UCD Aim 1 will: examine environmental, social, and biologic exposures in
associations with externalizing and internalizing behaviors, namely, symptoms of ADHD, anxiety
and depression at ages 8-20; and identify both synergistic relationships between environmental
and social factors, especially environmental justice and social justice, and potential modification
of exposure-outcome associations by early childhood developmental diagnosis (ASD, DD, TD),
age, sex and puberty status. Aim 2 will evaluate the same exposures, plus measures of PFAS
and plasticizers for associations with longitudinal trajectories of the above behavioral and
emotional outcomes, as well as cognitive skills. In both aims: environmental exposures include
air pollution, greenspace, and home product use; social factors are neighborhood SES, family
financial hardship, race, ethnicity, and parental mental health or substance use problems.
Aim 3 will implement the final ECHO protocol with high fidelity, maximize retention, and adhere
to all ECHO policies, IRB, HIPAA and other regulations. UCD will continue to contribute broadly
to the ECHO infrastructure; advance the science through analysis and publications; promote
diversity and equity through our research questions, workforce, and retention strategies; and
actively participate & play leadership roles in this high-profile, unique program to discover
underlying risk and resilience factors for childhood health and development.

Public health relevance
Project Narrative. Many youth are burdened with attention deficits, inattention, hyperactivity, anxiety or depressive mood, and these conditions can have long term serious consequences that impair their ability to succeed in school, obtain and keep productive jobs, get along with their peers, or find happiness. This project seeks to understand and identify some early childhood exposures, behaviors, or experiences that may increase risks for those problems, and ones that may help them avoid these issues. The public health importance of the proposed project is that finding out what changes a child’s risks or improves their outcomes can help public health agencies to design interventions to help children before the problems become severe or even before they know they are affected by these conditions.